The function of Snf5 (SMARCB1), an epigenetic tumor suppressor

Project Summary/Abstract:
SMARCB1 (SNF5/INI1/BAF47) is a conserved subunit of SWI/SNF chromatin remodeling complexes, which
utilize the energy of ATP hydrolysis to mobilize nucleosomes. A role for SWI/SNF complexes in cancer was
first suggested when SMARCB1 was identified as inactivated in virtually all cases of malignant rhabdoid tumor
(RT), a highly aggressive pediatric cancer. It has recently been discovered that nearly 25% of all human
malignancies carry mutations in SWI/SNF subunits. We established SMARCB1 to be a bona fide and potent
tumor suppressor and later demonstrated broad epigenetic antagonism between SWI/SNF and Polycomb
repressor complexes during oncogenic transformation. In subsequent work, including substantial progress in
the current funding period, we uncovered novel biological mechanisms and therapeutic vulnerabilities that form
the foundation for the aims described in this proposal. For example, we found that SMARCB1 is essential for
enhancer regulation, thus identifying a new mechanism underlying the tumor-suppressive activity of
SMARCB1. We and others also discovered the existence of a SWI/SNF complex that lacks SMARCB1,
previously considered a core subunit. Instead, this non-canonical complex contains the bromodomain protein
BRD9, which we also identified as a specific vulnerability in SMARCB1-deficient pediatric RTs. While our
findings demonstrate critical interactions of SWI/SNF and Polycomb complexes in transcriptional regulation
and cell fate control, the roles and contributions of SWI/SNF sub-families are unknown. Our first aim is
therefore to determine how SMARCB1-containing SWI/SNF complexes differ from mutually-exclusive BRD9-
containing SWI/SNF complexes in the antagonism of Polycomb interactions and transcriptional regulation.
Recent data from our group have shown that SWI/SNF complexes control histone acetylation and enhancer
function; however, the mechanism by which this leads to a mitotically heritable cancer phenotype is unknown.
Polycomb complexes remain bound to DNA during mitosis, but histone acetylation is erased and the SWI/SNF
ATPase, SMARCA4/BRG1 is phosphorylated and degraded. Thus, for our second aim, we propose to
determine how SWI/SNF complexes contribute to epigenetic memory during mitosis, including interrogating a
potentially paradigm-shifting model that is supported by preliminary data described in this proposal. Finally, we
identified the Polycomb subunit EZH2 as a vulnerability in RTs, inspiring the development of several clinical
trials and leading to recent FDA approval of EZH2 inhibitors for SMARCB1-deficient sarcomas. While
impactful, resistance to these inhibitors has emerged. To establish mechanisms driving drug resistance, we
have performed a near genome-wide CRISPR screen in EZH2 inhibitor-treated RTs, and for our third aim plan
to investigate the mechanism of resistance conferred by mutations in a gene not previously associated with
SWI/SNF functions. Taken together, these questions have potential for broad and substantive impact in
understanding the roles of these critical chromatin remodeling complexes in normal cells and in transformation.

Public health relevance
Project Narrative: SMARCB1 (SNF5), a subunit of SWI/SNF chromatin remodeling complexes, is specifically mutated in nearly all cases of malignant rhabdoid tumor, a highly lethal cancer of early childhood. Recent studies have revealed that genes encoding SWI/SNF complex subunits are mutated in nearly 25% of all human cancers, demonstrating that investigations of SMARCB1 function have broad cancer relevance. The proposed studies are designed to determine the normal function of SMARCB1, to define the mechanisms by which SMARCB1 mutations cause cancer, and to explore novel approaches for circumventing therapeutic resistance in these aggressive cancers.